Center for Gamma-Ray Imaging

DESCRIPTION (provided by applicant): The objectives of the Center for Gamma-Ray Imaging are to develop advanced gamma-ray detectors and imaging systems, to push the limits of spatial and temporal resolution in SPECT and PET, and to make state-of-the-art technology available to our collaborators and to the biomedical research community. Much of the emphasis is on basic research with animal models, but there are many possibilities for translating the technology and the results of the collaborative research into clinical practice. We strive to integrate the components of the P41 mechanism (core technology development, collaborative research, service, dissemination and training) into a comprehensive program that addresses all aspects of gamma-ray imaging, including the radiopharmaceutical, image formation and detection, data acquisition and processing and the final biomedical application. The core technology projects include development of new gamma-ray and charged-particle detectors with high sensitivity and high spatial and temporal resolution; design and construction of new imaging systems incorporating sophisticated list-mode data-acquisition electronics; rigorous task-based evaluation and optimization of imaging systems and algorithms; design and analysis of adaptive and multimodality systems; and development of image-acquisition and image-analysis methods for molecular imaging. Collaborative research includes projects in cancer diagnosis and therapy, neurological and cardiovascular disease, stem cells, image science in nuclear medicine, and imaging biomarkers. Dissemination includes supplying imaging hardware and software to our collaborators, as well as workshops and a web site for traditional dissemination of information. Training includes both formal short courses and hands-on training for our collaborators in Tucson. Service includes performing routine animal studies, testing and calibrating detectors and detector materials, and providing advice on image quality.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT (PROVIDED BY APPLICANT): MISSING FROM APPLICATION. _______________________________________________________________________________